Expression of dystrophins with enhanced function

Project Summary/Abstract
Duchenne muscular dystrophy (DMD) is an X-linked, lethal recessive genetic disorder resulting from mutations
in the DMD gene, which encodes the protein dystrophin (Dys). The 2.2 MB gene displays the highest new
mutation rate of any human gene, reflecting the high DMD prevalence (1:5,000). This large size coupled with
thousands of unique mutations creates significant complexity for gene therapy. Previous studies by us and others
led to the design of ‘micro-dystrophins’ (μDys) that can be delivered systemically to striated muscles using AAV
vectors. This approach, along with anti-sense oligonucleotide (ASO) ‘exon-skipping’ methods, have emerged as
promising therapies that are being tested in multiple clinical trials, with one µDys approach and several ASO
drugs having now been approved by the FDA. Gene editing has garnered significant attention, primarily as an
alternate and potentially permanent way to correct Dys expression. While promising, the ASO & editing methods
remain comparatively inefficient, and many AAV-mediated editing methods result in genomic rearrangements &
vector insertion due to Cas9-induced double-stranded DNA breaks. AAV-μDys has proven to be far more efficient
& is not associated with insertional mutagenesis; however, this approach is limited to delivery of dystrophins
carrying only one-third of the full-length sequence. Clinical trials, while encouraging, have also revealed dose-
related toxicities that limit the AAV dose, which is suboptimal for gene replacement & editing. Our ongoing
structure/function studies of Dys have led to the design of numerous micro-, mini- and full-length Dys vectors, &
have extended into gene editing methods. Together these approaches offer the potential to express significantly
larger and more functional dystrophins. Furthermore, myotropic AAV capsid variants now enable delivery of more
potent gene therapies at much lower vector doses. In this proposal we harness previous discoveries and
preliminary data to address limitations of current gene therapy approaches for DMD by developing improved
gene replacement & editing vectors. In Aim 1, novel technologies for expressing mini- & full-length Dys and/or
it’s paralogue utrophin (Utrn) using multiple AAVs will be refined with the goal of efficiently producing highly
functional therapies. This approach utilizes known & novel split inteins to enable production of Dys/Utrn proteins
larger & more functional than can be delivered with a single AAV vector (i.e. AAV-μDys). In Aim 2, enhanced
Dys gene editing methods will be developed to maximize duration and expression levels of large endogenously
regulated dystrophins, through delivery of augmented & inducible editing vectors. A major focus is on Satellite
cells. Aim 3 critically evaluates the therapeutic impact & longevity of both Aim 1 & 2 approaches in response to
aging & injury, and examines the possibility for synergistic application. All aims take advantage of the recently
described ‘MyoAAV’ capsids that enable systemic muscle gene delivery at doses 10-20-fold lower than the AAV9
or rh74 serotypes currently in clinical trials. Together these approaches could significantly increase the safety
and efficacy of gene therapy for DMD, and should have important applications to other neuromuscular disorders.

Public health relevance
Project Narrative This proposal addresses emerging limitations to approaches for gene therapy of DMD. Gene replacement methods will be advanced by developing new methods to deliver larger dystrophins, while gene editing approaches will be refined by applying multiple tools to advance editing into stem cells & the clinic.